Metabolic mechanisms of cognitive decline in aging and AD mediated by inflammatory PGE2 signaling

Metabolic mechanisms of cognitive decline in aging and AD mediated by inflammatory PGE2 signaling
Project Summary
Aging is characterized by the development of maladaptive immune responses that promote cognitive decline
and Alzheimer’s disease (AD). We recently identified the inflammatory lipid messenger prostaglandin E2
(PGE2), signaling through its EP2 receptor, as a major driver of age-associated inflammation and cognitive
decline. Genetic deletion of the EP2 receptor in myeloid cells was sufficient to prevent systemic and brain
inflammation and cognitive decline in aging mice. Myeloid EP2 deletion rescued healthy immune cell
responses by restoring glucose flux and downstream mitochondrial respiration in aging macrophages and
microglia. We also made the surprising observation that peripheral inhibition of EP2 signaling with a non-brain
penetrant EP2 antagonist phenocopied the effect of pan-myeloid EP2 genetic deletion. These data suggest
that peripheral inhibition of pro-inflammatory PGE2 signaling is sufficient to restore healthy hippocampal
function in aging mice. In this proposal, we will build on these initial findings and define how metabolically
reprogrammed myeloid cells in the periphery can elicit effects beyond the blood-brain barrier (BBB) that
reverse changes in hippocampal function in models of aging and AD pathology. We will test the hypothesis
that the beneficial immune-metabolic effects of EP2 inhibition on myeloid cells in the periphery are transmitted
from the blood to the cerebral endothelium and then to astrocytes, leading to improved astrocytic support of
neurons. We will employ preclinical models of aging and mutant APP lines, targeted metabolomics and
transcriptomics to understand how improving peripheral myeloid energy metabolism leads to beneficial effects
beyond the blood brain barrier. We will test whether peripheral EP2 immune blockade, by reprogramming
circulating blood, will improve endothelial function. We will then test whether astrocytes, whose foot processes
envelop the capillary bed are in turn functionally improved. As astrocytes support neuronal metabolism, we
hypothesize that peripheral EP2 inhibition will improve astrocytic support of neurons, leading to improved
cognitive function in models of aging and AD.

Public health relevance
Project Narrative We have recently identified a major inflammatory pathway driven by the lipid messenger prostaglandin E2 (PGE2) that drives age-associated inflammation and cognitive decline. Inhibition of this pathway restores healthy immune responses and cognitive function. The research objective of this proposal is to understand how peripheral inhibition of this inflammatory pathway is transduced from the periphery, across the blood brain barrier, to the brain, and how it restores cognitive function in models of aging and Alzheimer’s disease.